ROLE OF ENDOTHELIUM ON MYOCARDIAL INFARCTION INJURY RESPONSE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We are collaborating with the Dr. Pu to explore the role of epicardium in postnatal cardiac homeostasis and injury response using our mouse endothelial cell lines.